BioMolecular Networks in Antibiotic Resistance Evolution

DESCRIPTION (provided by applicant): The overall objective of the proposed K25 career development program is to provide a period of mentored didactic and research training that will allow the candidate to focus his quantitative background in metabolic engineering on research questions of health and disease. The specific objectives are i) to receive didactic training in bacterial pathogenesis, ii) to obtain mentored guidance in clinical microbiology, molecular evolution, and microbial evolution research, and iii) to develop a foundation for future research endeavors that use, develop, and combine genomics and bioinformatics tools to better understand bio-molecular network evolution within the context of bacterial pathogenesis and antibiotic resistance. Research Description. Fluoroquinolone resistance is known to occur in a step wise fashion often involving a combination of decreased drug accumulation or target affinity. The unusually rapid adaptability and surprisingly high number of transport related genes in P. aeruginosa has complicated efforts to understand the emergence of fluoroquinolone resistance in this organism. For example, there are 88 genes in P. aeruginosa with known or putative efflux functions. The relevance of each of these and other potential cryptic resistance genes in the evolution of fluoroquinolone resistance is not known. The 1st major objective of this study is to identify, using an unbiased, genome-wide approach, and characterize cryptic fluoroquinolone resistance genes in P. aeruginosa with respect to the relative costs and benefits to biological fitness and virulence associated with each gene (Aims 1-2). Using network theory, we hypothesize that resistance mutations in genes with a large number biological interactions will impose a higher cost than mutations in genes with a small number of biological interactions. The 2nd major objective of this study is to further develop several genomics/bioinformatics tools that will allow us to test this hypothesis (Aims 3-4).